Caregiver–Child Proximity and Attachment Security

PROJECT SUMMARY/ABSTRACT
Research has shown that the security of a child's attachment to their primary caregiver is crucial to their social
relationships and overall well-being. Attachment security is developed through contingent and responsive
interactions between the child and caregiver, with physical proximity playing a vital role in building trust.
Despite the importance of real-world caregiver–child interactions, previous research has largely focused on
laboratory-assessed caregiver quality. To address this gap, we have developed a wearable device called
TotTag, which can dynamically and unobtrusively measure real-time physical proximity between device
wearers. TotTags are worn in vests by children and in waistbands by caregivers to assess patterns of close
contact in children's everyday lives. In this NIH exploratory/developmental research grant, we plan to recruit
100 families with a 12-month-old child from diverse racial, ethnic, and socioeconomic backgrounds. During a
home visit, we will assess caregiver sensitivity with up to two caregivers per child. Each caregiver and the
infant will then wear TotTags from the child's wake time to bedtime (~12 hours) to assess time in close
proximity and the number of caregiver–child "check-ins" (i.e., periods of close contact between periods of
separation). Finally, we will conduct the Strange Situation Procedure to assess attachment security with each
available caregiver. Aim 1 will explore aspects of caregiver–child proximity in relation to attachment security.
Aim 2 will examine the potential additive and interactive contributions of caregiver sensitivity and caregiver–
child proximity in relation to attachment security. By obtaining sensitivity and proximity data at the dyad level
(e.g., child with mother; child with father) within a family, we aim to gain insight into the specific aspects of each
caregiver–child relationship associated with attachment security. Furthermore, this rich intensive longitudinal
data of proximity patterns will be made available to allow for exploration of other relevant questions of interest
(e.g., associations with family structure; weekend vs. weekday patterns). In addition, we will obtain information
regarding the fidelity and acceptability of ecological assessments in families with infants in anticipation of a
larger program of research examining the longitudinal development of attachment starting in early infancy. This
cross-sectional study, using innovative new technology coupled with home-based caregiver sensitivity
assessments and gold-standard laboratory assessments of attachment, will provide an unprecedented picture
of infants' daily experiences with their caregivers. Findings from this study will aid in setting the foundation for
future work focused on fostering healthy development through secure attachment relationships.

Public health relevance
PROJECT NARRATIVE Secure attachment relationships set the foundation for later functioning, including social relationships, health, and well-being; yet, we know little about the daily contexts that foster attachment relationships between infants and those who care for them. Addressing the need for more ecologically-valid approaches to our understanding of children’s early caregiving experiences, this study uses the TotTag—a wearable device that can dynamically and unobtrusively measure patterns of physical proximity between children and caregivers continuously, regardless of location—to allow for assessments of time children spend in proximity to their caregiver in addition to caregiver sensitivity. The insights gained regarding the association between attachment security from two aspects of caregiving will help set the foundation for a better understanding of how caregiving behavior may promote attachment security.